Defining adaptive immune responses to Mtb-infection and TB disease among young children with and without HIV-exposure

PROJECT SUMMARY
Tuberculosis disease (TB), caused by Mycobacterium tuberculosis (Mtb) is a leading cause of morbidity and
mortality in young children <5 yr old. The vulnerability of young children to develop TB following primary infection
is not understood; this critical knowledge gap hampers efforts to develop a more effective vaccine and improved
diagnostic tests for this high-risk population. HIV-exposed (HEU) children are the majority of children living in the
homes of HIV+ adults, where they are more likely than HIV-unexposed-uninfected (HUU) children to be TB
exposed. Clinical, epidemiologic, and immunologic findings support that young, HEU children will exhibit
distinctive immune responses following Mtb-exposure; however, immune responses to Mtb-infection have not
been characterized in this high-risk population. Our proposal will comprehensively define adaptive immune
responses to Mtb-exposure and TB in children < 5yr using a pediatric TB household contact (HHC) study based
in Kampala, Uganda, where up to 20% of children are HEU. Our approach will identify unique immunologic
biosignatures driven by where the child sits on the TB disease spectrum, as well as by HIV-exposure status. We
hypothesize that immune biosignatures of Mtb-exposed asymptomatic HEU children will more closely resemble
those observed among children with TB, as compared to asymptomatic HUU children. If proven, this would
suggest that Mtb-exposed HEU children are more likely to be experiencing a pre-clinical rather than quiescent
or latent Mtb-infection. Such findings would have implications for the development of immune-based diagnostics
for Mtb-infection and TB disease that may perform differently in HIV-exposed and unexposed children, as well
as clinical management and monitoring of HEU-children following TB exposure. Working with a biorepository of
samples obtained from Ugandan children < 5 yr, and a proposed prospective cohort of Ugandan children < 5 yr
who are TB HHC, we will address three specific aims that: 1) define longitudinal, functional and phenotypic Mtb-
specific adaptive immune responses among young children who developed TB or remained asymptomatic; 2)
develop a pool of novel Mtb-epitopes and focused flow cytometry-based assay customized to detect Mtb-specific
T cell responses in young children; and 3) establish a unique Mtb-specific antibody Fc profile that defines children
with TB. Our proposal will advance pediatric global health by: 1) identification of immunologic signatures
reflecting successful containment of primary Mtb infection that can serve as correlates of protective immunity for
novel vaccine trials; 2) development of novel blood-based assays that discriminate between young children with
TB and those whom have been exposed but successfully contained their infection.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb) is a leading cause of morbidity and mortality in young children <5 yr. old, especially children with underlying HIV-infection (HIV+). The vulnerability of young HIV- exposed and unexposed children to develop TB following primary infection is not understood, and current diagnostic tools perform poorly. Our proposal will advance pediatric global health by: 1) identification of immunologic signatures reflecting successful containment of primary Mtb infection that can serve as correlates of protective immunity for novel vaccine trials; 2) development of novel blood-based assays that discriminate between young children with TB and those who have successfully contained their infection.